Closed-loop epidural stimulation: respiratory motor plasticity and neural underpinnings

PROJECT SUMMARY/ABSTRACT
Each year there are more than 17,000 new spinal cord injuries in the United States, half of which occur at the
cervical level. These cervical injuries lead to breathing dysfunction and reliance on mechanical ventilation,
making respiratory failure the leading cause of mortality after injury. Sub-threshold (current amplitude below that
necessary to directly activate motor pools) electrical stimulation of the dorsal epidural surface of the spinal cord
can elicit voluntary locomotor function in injured patients, but its ability to improve breathing capacity is largely
unexplored. Prior study from the Dale lab demonstrates that chronic application of closed-loop stimulation in
unanesthetized rats leads to lasting increases in phrenic motor network excitability, and that this effect is blocked
by removal of cervical dorsal afferents. Additionally, work recently published by the candidate shows that closed-
loop stimulation recovers spontaneous diaphragm EMG immediately after injury and this lasts for short periods
after stimulation has stopped. However, neither the conditions necessary to best elicit lasting increases in
respiratory output nor closed-loop stimulation’s mechanism of action are well understood. Ideally, a stimulation
paradigm which improves breathing function both during and after treatment would lead to device independence
and improved quality of life. Therefore, it is critical to thoroughly understand the functional and neuroplastic
effects of epidural stimulation as well as the neural populations responsible for its action. The central
hypothesis of this fellowship is that multiple bouts of closed-loop epidural stimulation elicit lasting
improvements in breathing function which requires sensory feedback which we propose to test through
two aims: 1) Using a well-defined, acute C2-hemisection injury (e.g. maintaining contralesional diaphragm
function), we will assess the effect of closed-loop epidural stimulation paradigms on evoked and spontaneous
diaphragm EMG activity and inspiratory pressure generation during and after stimulation; 2) Using innovative
mechanical ventilation techniques in our acute model, we will determine the necessity of sensory feedback and
descending inputs in mediating epidural stimulation’s effects. Primary mentor Dr. Dale is well-funded, has
extensive experience with both acute and chronic models of spinal cord injury, and initially developed the closed-
loop stimulation paradigm utilized in this proposal. Co-sponsor Dr. David Fuller is a leading expert in respiratory
neurobiology research and has an extensive track record in mentorship with over 80% of his trainees moving on
to faculty or post-doctoral positions (2 prior mentees have received F31s). The training plan was designed to
further the candidate’s goal of becoming an independent PI and includes attendance at local and national
conferences, participation in seminars and journal clubs, and development of laboratory management, teaching,
writing, and mentoring skills. This fellowship will provide critical understanding of epidural stimulation’s
functional effects and mechanism necessary to translate this treatment to clinical populations while
helping develop the career of a promising young scientist.

Public health relevance
PROJECT NARRATIVE Spinal cord injury can paralyze breathing muscles, which makes people reliant on mechanical breathing support. Electrical stimulation of the spinal cord has been able to improve walking ability after injury, but this treatment has not been studied for restoring breathing. In this proposal, we will explore the use of electrical stimulation to increase breathing ability both during and after stimulation, and determine if sensory feedback is necessary for stimulation’s effects.